Ethanol and mGluR2 signaling

Project Summary
Current NIAAA strategic plan calls for efforts to identify novel molecular actions of alcohol and new remedies to
mitigate alcohol-impacted brain regions. Ever-changing research tools have exponentially accelerated our
understanding of brain regions and circuits affected by alcohol use and comorbid affective disorders. However,
efforts towards the understanding of molecular mechanisms for altered neural activity in these impacted
regions have lagged behind. To fill in this gap, we will explore a previously unknown molecular mechanism
whereby ethanol modulation of brain cholesterol in the prefrontal cortex (PFC) leads to aberrant mGluR2
function and glutamate transmission in a rodent model of chronic intermittent ethanol (CIE) exposure. This
modulation may thus contribute to alcohol drinking and anxiety-like behavior, commonly observed in patients
with alcohol use disorder (AUD). Using a CIE rodent model, we show that CIE increases glutamate release in
the PFC along with increased alcohol drinking and anxiety-like behavior. Further, we and others report that
ablation of PFC neuron projection to subcortical regions (e.g. BLA or NAc) abolishes these behaviors. Thus,
the PFC is a critical hub for regulating dependence-related neural and behavioral activity. However, the
molecular mechanisms underlying CIE-induced disruption of glutamate transmission in the PFC remain
elusive. Our preliminary data strongly suggest mGluR2 involvement in this region: a) CIE spatially segregates
mGluR2 from Gαo subunit and reduces mGluR2 stimulation of Gαi/o; b) CIE abolishes mGluR2 inhibition of
Gβγ-mediated presynaptic glutamate release and postsynaptic intrinsic excitability of PFC neurons; and c) CIE
impairs mGluR2 inhibition of anxiety-like behavior. Such a deficit in mGluR2 function may be governed by
membrane cholesterol. We found that CIE drastically increases cholesterol content in the PFC by enhancing
the activity of HMG-CoA-reductase (HMGCR), a cholesterol synthesis enzyme. Importantly, reduced, CIE-
dependent mGluR2 function can be reversed by ex vivo cholesterol removal and mimicked by ex vivo
cholesterol addition to naïve tissue. We hypothesize that blockade of cholesterol increase will attenuate CIE-
dependent disruption of mGluR2-mediated G-protein activation, neurophysiology and dependence-related
behaviors. We will use CRISPR/Cas9, cellular, electrophysiological and behavioral approaches to test our
hypothesis. The proposal is conceptually and technically innovative and significant, investigating a largely
overlooked and potentially impactful effect of CIE exposure on cholesterol modulation of mGluR2 function,
glutamate transmission and anxiety-like behavior.

Public health relevance
Project Narrative Chronic alcohol exposure produces profound changes in neurotransmission. This project investigates the relationship between chronic alcohol exposure, brain cholesterol metabolism and glutamate transmission. Completion of this project may provide new molecular targets for potential therapeutic intervention of alcohol use disorder.